Blood amyloid, tau, and neurodegeneration biomarkers and prediction of clinical onset, cognitive decline, and dementia diagnosis

PROJECT SUMMARY
In order to accelerate observational clinical studies and trials and to identify appropriate patients for treatments,
highly accurate and accessible diagnostic tests for Alzheimer's disease (AD) are needed. Clinical assessments
alone are insufficient for accurate diagnoses, and the current gold standard tests for AD (CSF and PET) are
costly, limited to specialized medical centers, and perceived to be invasive. In our ongoing prospective Study to
Evaluate Amyloid in Blood and Imaging Related to Dementia (SEABIRD), we discovered that decreased blood
plasma Aβ42/40 ratio is an accurate biomarker of amyloid plaques and confirmed this in a diverse community-
based population, also demonstrating that blood tests are feasible to screen the general population.
We have discovered and reported the most accurate Aβ42/40 and phosphorylated-tau blood biomarkers
(%ptau217, %ptau205, and %ptau181) and discovered novel forms of neurofilament light (NfL) that promise to
quantify the major domains of AD pathophysiology. With demonstration that removal of amyloid plaques leads
to disease-modifying treatment clinical benefits, access to anti-amyloid therapies will depend on accurate
diagnosis, and blood biomarkers will be critical tools for doctors and patients in underrepresented populations.
However, there are multiple questions that need to be addressed to inform about the biology, use, and indications
of these rapidly developing and utilized blood-based biomarkers. These questions include: `What are the
diagnostic and prognostic properties of blood Aβ, tau, and neurodegeneration (A/T/N) biomarkers to measure
amyloid and tau pathology, clinical cognitive decline, and diagnosis in a real-world clinical patient population?',
and `Which demographic, clinical, or genetic factors influence the relationship of blood A/T/N biomarkers to the
gold standards of clinical cognitive decline, dementia, and PET tests of pathology?'
Our proposed study, called SUNBIRD (Study to Understand Novel Biomarkers in Researching Dementia), will
enroll 1000 new participants from primary and specialty care clinics and follow the existing ~1000 SEABIRD
participants. We will incorporate high performance blood-based biomarkers tracking amyloid, tau and
neurodegeneration and assess their relationship with tau PET, amyloid PET, and other clinical AD tests. We will
follow these cohorts longitudinally using blood samples, EHR data, and in-person and remote cognitive testing.
We aim to understand how blood-based biomarkers can identify those with clinical symptoms due to AD
pathology, determine if blood-based biomarkers can be utilized in lieu of PET or CSF measures, and also
diagnose and stage patients to enable treatment and prevention in the clinic. The proposed work builds on the
prior pioneering approach that discovered and validated blood amyloid biomarkers, discovered novel tau
phosphorylation sites. These studies will lay the groundwork for rapid deployment to accelerate enrollment of
AD trials, clinical diagnosis, and early and accurate diagnosis for the whole population.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease (AD) is the most common cause of dementia and currently has few disease-modifying treatments or simple, accurate diagnostic tests available in the clinic. The goal of this project is to further develop and validate amyloid, tau, and neurodegenerative blood tests for amyloid plaques (a protein thought to begin AD) and tau tangles (protein deposits closely associated with cognitive impairment) in order to diagnose AD in the clinic to enable treatment with disease-modifying drugs, which could change the course of AD. Findings from this study may enable accurate diagnoses and access to more effective treatments of AD.